Epigenetic Regulation of Langerhans Cell Histiocytosis Pathophysiology and Microenvironment by HDAC3

PROJECT SUMMARY/ABSTRACT
Langerhans cell histiocytosis (LCH) is a rare inflammatory myeloid neoplasm with a wide range of clinical
manifestations and severity caused by mutations that constitutively activate mitogen-activated protein kinase
(MAPK) signaling in myeloid lineage cells- most commonly BRAFV600E. Constitutive MAPK activation endows
pathological histiocytes with a senescence associated secretory phenotype (SASP)- leading to resistance to
apoptosis, increased inflammatory cytokine and matrix metalloproteinase expression, and decreased ability to
migrate to lymph nodes. These features allow LCH cells to persist in tissues and reshape the microenvironment
leading to the characteristic granulomatous lesions harboring CD207+ cells. However, little is known about tissue-
specific and time-dependent features of the LCH microenvironment (LCH-ME).
Treatment of LCH remains unacceptable due to significant drug-induced toxicity and inability of current
treatment strategies to eliminate LCH precursor cells leading to high-rates of disease recurrence. Recurrence
often leads to life-threatening sequalae. Drugs targeting both development and homeostasis of LCH cells could
revolutionize treatment for patients with LCH. Our lab showed histone deacetylase 3 (HDAC3) regulates multiple
facets of myeloid cell biology, including development and homeostasis. This F30 proposal seeks to define the
therapeutic potential of targeting HDAC3 to ameliorate LCH. Collectively, the data presented will further our
understanding of the epigenetic regulation of pathological myeloid cells, provide novel insights to the LCH-ME,
and provide preclinical data for HDAC3 inhibition (HDAC3i) as a treatment for LCH.
In Aim1, we will us a mouse model of LCH to define tissue-specific and time-dependent features of the
LCH-ME. Using flow cytometry, single-cell RNA sequencing, and imaging mass cytometry we will compare the
composition, gene expression, and spatial organization of lung and liver LCH lesions over time.
In Aim2, the efficacy of HDAC3i will be evaluated in a mouse model of severe-multifocal LCH. Using
genetic ablation and pharmacological inhibition, we will test how HDAC3i influences development, homeostasis,
and SASP properties of LCH cells, and the LCH-ME. These studies will address a major gap in our
understanding of LCH disease development and define a potential new therapeutic that could be
translated to treat LCH and other MAPK-driven histiocytic disorders.
The training plan outlined in this proposal will be performed between Henry Ford Health System, Wayne
State University School of Medicine, and Karmanos Cancer Institute, which presents a unique opportunity to
leverage the advantages and expertise at all three institutions providing a robust clinical and research training.
Executing this training plan in such a vibrant multi-institutional environment, with the guidance of dedicated
sponsors, collaborators, and mentors with expertise in immunology, epigenomics, cancer biology, and
hematology, will provide an unparalleled training for a successful career as a physician-scientist.

Public health relevance
PROJECT NARRATIVE Langerhans cell histiocytosis (LCH) is an often-lethal inflammatory myeloid neoplasia that arises due to mutations (most commonly in the protein BRAF) that persistently activate the mitogen-activated protein kinase (MAPK) signaling pathway in myeloid lineage cells, which alters their physiology leading to accumulation of LCH cells in tissues and reshaping of the tissue microenvironment. Current treatment strategies, which include chemotherapy or inhibitors of MAPK signaling have significant toxic side-effects and do not eliminate LCH cell precursors leading to recurrent disease and deleterious life-long complications. Recent studies from our lab have identified that the epigenetic protein HDAC3 modulates many facets of myeloid cell biology, including development, making it a promising therapeutic target that may provide persistent disease remission for patients with LCH.